Quantitative Imaging Analysis to Identify Chronic Respiratory Disease

Chronic respiratory diseases (CRDs), such as chronic obstructive pulmonary disease (COPD) and
interstitial lung disease (ILD) are currently the 4th leading cause of death in the U.S., yet often remain
undiagnosed and under-treated until the advanced stages. Current research suggests an increased
prevalence and rising incidence of CRDs among Veterans relative to the general population. Yet, despite a
high prevalence and evidence supporting improved outcomes with early medical management, no screening
programs currently exist for CRDs. Chest computed tomography (CT), a medical imaging modality employed
for lung cancer screening (LCS), can detect structural changes in the lungs associated with CRDs, but their
use has been limited by (1) the labor-intensive nature and inter-person variability of visual interpretation of
images, (2) clinical reports which are often focused solely on acute findings (lung nodules, pneumonia) with
inconsistent reporting of chronic conditions. Quantitative imaging analysis (QIA) techniques have been
developed which can objectively detect and quantify a broad range of pathological changes directly from chest
CT imaging data, often with increased sensitivity relative to visual methods. We assert the application of QIA
to clinically obtained chest CT data within the auspices of well-organized LCS program represents an
opportunity to identify and characterize undiagnosed CRDs among a high-risk Veteran population.
We propose to develop and validate a clinical tool, the Quantitative Imaging Analysis-based Risk
Summary (QIA-RS), which will translate imaging information from LCS chest CTs into practicable evidence
in three CRD domains: lung function impairment, symptoms and functional status, and future respiratory
healthcare utilization. QIA will be performed using TRM-approved software behind the VA firewall to assess
features of CRD (e.g. emphysema, airway wall thickness, interstitial lung abnormalities, and total lung
capacity) on archived and newly acquired chest CT data from patients enrolled in the VA Boston LCS program
(4,777 unique referrals between 2017-2019, with ~1400 new referrals/year). Clinically-ascertained spirometry
available in approximately 2,400 subjects, will be used to train and validate models to predict lung function
impairment using QIA features as predictors (QIA-RS lung function impairment domain – Aim 1). Because
individuals with undiagnosed CRDs (the target population for our QIA-RS tool) have been incompletely
characterized in the literature, we propose to recruit individuals with no previous history of lung disease at the
time of LCS (n=300) for an in-person study visit where lung function, respiratory symptoms, and functional
status (exercise capacity, health related quality of life) will be assessed and used to identify thresholds of QIA-
assessed features associated with impairments (Aim 2 – QIA-RS respiratory symptom and functional status
domain). We will follow individuals recruited in Aim 2 (n=300) via telephony and medical record review for 12
months to assess prospective (a) respiratory events (telephone, outpatient, urgent care / emergency,
hospitalization encounters for respiratory symptoms) and (b) new respiratory medication use and will integrate
data on lung function and respiratory symptoms (Aim 2) and common and low abundance inflammatory
markers to refine risk estimates for QIA-assessed features as predictors of respiratory outcomes (Aim 3 –
QIA-RS respiratory healthcare utilization domain). The validated QIA-RS tool, which will provide succinct
reports of risks associated with CRDs along with actionable recommendations for care, represents a scalable,
imaging-based solution to identify and risk stratify previously undiagnosed CRDs among Veterans. This
application of QIA technology to clinically-ascertained imaging studies represents an innovative and efficient
use of existing data to promote the delivery of personalized care for individual Veterans and will assist in
resource allocation for disease management at the organizational level.

Public health relevance
Veterans are at higher risk for chronic respiratory diseases (CRDs), including chronic obstructive pulmonary disease (COPD) and interstitial lung disease, relative to the general population due to deployment-related and occupational exposures and increased rates of smoking. Although early diagnosis and treatment can improve outcomes, no screening programs for the early detection of CRDs currently exist – as a result, many CRDs are detected late, often when symptoms are severe. Unlike for CRDs, screening programs for lung cancer using low-dose chest computed tomography (CT) scans do exist and changes in the lungs due to CRDs can be detected on these studies. This project will use specialized computer software to analyze chest CT scans obtained for lung cancer screening to detect changes in the lungs due to CRDs. These computer measurements will be used to develop a tool to help identify undiagnosed CRD among Veterans so that they may receive timely, personalized care.